Identification of Specific Immune Responses in African American Female Patients with Hidradenitis Suppurativa

Project Summary
Hidradenitis suppurativa (HS) is a multifactorial chronic, debilitating, inflammatory skin disorder
characterized by painful nodules, abscesses, sinus tracts, and scar formation in intertriginous
skin. Most HS patients experience low quality of life likely due to the associated pain, disease
severity, comorbidity conditions, and psychological discomfort. HS affects all races; however, sex
and racial disparities exist with a female to male ratio about 3:1 and increased prevalence,
severity, and dermatologic care in African American and Hispanic/Latino patients compared to
White patients. Despite these differences, contributing factors to these disparities in HS are
largely understudied. Although multiple studies have provided evidence of genetic contribution to
HS, only one genome-wide association study of HS susceptibility has been published, creating a
gap in our knowledge of the pathogenesis of HS. Our main hypotheses are as follows: germline
variation contributes to HS risk in African American, Hispanic/Latino, and White patients; ancestral
differences in genetic risk loci likely account for the racial disparity in HS risk; and sex-specific
genetic risk loci partially influence the sex disparity in HS. We will use whole-genome sequencing
(WGS) to comprehensively assess the associations of rare and common genetic variants across
the genome with HS. We will leverage data from our unique cohorts and other existing genetic
resources including the All of Us WGS data to test our hypothesis through the following specific
aims. In Aim 1, we will perform WGS analysis of HS in African American, Hispanic/Latino, and
White individuals via single-variant and rare-variant burden association tests for each population.
We will determine the effect of genetic ancestries on HS risk and identify the variation in regional
chromosomal ancestries associated with HS in admixed individuals (African Americans and
Hispanic/Latino Americans) via admixture mapping. In Aim 2 we will conduct trans-ethnic meta-
analyses of WGS data to identify both shared and population-specific genetic risk loci and
determine whether HS-associated variants are shared between females and males or sex
specific. In Aim 3, we will seek to identify cell-specific immune related genetic loci, and through
comprehensive multi-omics analysis identify functionally relevant variants to be validated
mechanistically. Successful completion of this proposal will provide insights into the genetic
contributions to risk of HS, including mechanistic exploration of the genes identified that will lead
to the development of new therapeutic targets and treatments in HS.

Public health relevance
Project Narrative Hidradenitis suppurativa (HS) is a chronic inflammatory skin disease characterized by painful skin alterations in the skin-fold areas leading to low quality of life, with racial and sex disparities. However, the pathogenesis of HS and contributing factors to the disease disparities are poorly understood. The overall goal of this project is to define the genetic contributors to HS risk using whole-genome sequencing and functional genomics, which may uncover the pathogenesis of HS, leading to new therapeutic targets and treatments for HS patients.